Lineage tracing origins of human innate lymphoid cells from hematopoietic precursors

Project summary
Human natural killer (NK) cells are critical for control of viral infection and their importance for human health is
underscored by the disease that results from dysregulated NK cell development or function. In the adult, NK cells
are continuously generated from stem cells, making their generation an important process for human immunity.
Despite the importance of this continuous generation, there is much that is still unknown about how stem cells
with the potential to become any blood cell are directed to become an NK cell. This process is further
complexified by the observation that myeloid progenitors can give rise to NK cells under certain conditions. Here
we propose to address these questions using genetic ‘barcoding’ of human pluripotent stem cells combined with
their differentiation to NK cell lineages. This experimental approach will be used to delineate the emergence of
innate lymphoid cells from stem cells with single cell resolution. Aim 1 will optimize a novel genetic cell tracing
system and use it to generate transcriptomic trajectories of NK cell differentiation from lymphoid or myeloid
committed progenitors. Aim 2 will pair this reporter system with live cell imaging of cell dynamics as NK cells
undergo differentiation to understand the dynamic interactions that give rise to human NK cells. Together, these
aims will define the emergence of NK cells from multipotent progenitors and provide a mechanistic, single cell
resolution understanding of how lymphoid and myeloid progenitors give rise to functionally mature innate
lymphocytes.

Public health relevance
Project narrative Natural killer cells are immune cells that play a critical role in controlling viral infections and fighting cancer. Despite their importance, little is known about how developing NK cells receive signals required for their differentiation. This project will generate novel lineage tracing methods to define emergence of human NK cells from multipotent progenitors and define the transcriptomic trajectories of human NK cells.